Development and initial testing of a shoulder-hand active-passive exoskeleton (SHAPE) to assist individuals with chronic upper-extremity impairments after stroke.

The PI, Joseph Kopke, is a PT and Ph.D., trained at Northwestern University after serving in the US Air Force
for 8 years. His dissertation research focused on understanding control of the shoulder and the feasibility of
using machine learning to control a powered device to support the shoulder against gravity after stroke. His
immediate goal is to develop a hybrid exoskeletal system utilizing a passive shoulder and an active hand
(Shoulder-Hand Acitve-Passive Exoskeleton, SHAPE) to assist individuals after stroke. He would like to advance
this project towards a follow-on efficacy study as part of a CDA-2. Ultimately, his goal is to bridge the gap between
the clinic, neuroscience, engineering, and the patient and bring simple, smart, intuitive devices to Veterans to
address impairments and increase function after neuro insult.
He is supported by a strong and experienced team of mentors including Dr’s Matthew Major (Ph.D.), Levi
Hargrove (Ph.D.), Elliott Roth (MD), Stefania Fatone (Ph.D., BPO) and poised between three top-tier institutions
Jesse Brown VAMC, Northwestern University, and Shirley Ryan AbilityLab. His mentorship team offers him a
breadth and depth of knowledge and experience essential to the success of his proposal. His primary mentor,
Dr. Major will provide oversight of the project and Dr. Kopke’s training and development; Dr. Hargrove provides
the expertise in pattern recognition and imbedded control while Dr Roth provides over 30 years experience as a
clinician scientist working with individuals with stroke and other neurological impairment; Dr. Fatone will offer
insight and guidance as a trained orthotist with years of upper-extremity device development experience.
Together they offer Dr. Kopke the opportunity to develop towards an independent VA movement scientist
committed to bettering the function and quality of life of Veterans through orthotic technology.
This proposal focuses on the development of the Shoulder-Hand Active-Passive Exoskeleton (SHAPE) for
individuals with chronic upper-extremity impairment after stroke. Common impairments after a cerebrovascular
accident, or stroke, include extreme weakness throughout the shoulder, arm, wrist, and hand, limiting their use.
Additionally, increased abnormal tone that presents during effortful tasks further impairs the individual by causing
unintentional and abnormal muscle activation throughout the limb. Supporting the shoulder to move the arm
against gravity minimizes this abnormal tone and enables better elbow, wrist, and hand function. Combining
shoulder support with a hand device designed to facilitate extension and grip will then address both the weakness
experienced in these areas as well as minimize secondary negative effects caused by use of the shoulder.
The purpose of Aim 1 is to design and refine a wearable passive shoulder support device to help compensate
for gravity. A prototype to passively support glenohumeral elevation has already been designed and fabricated
using low-cost materials. An iterative phase-gate approach incorporating user feedback will be implemented to
advance this design from prototype to a more definitive device that is comfortable and effective. Functionality
will be assessed in a small number of participants with and without the shoulder portion of SHAPE through
measuring shoulder range of motion, Fugl-Myer upper-extremity assessment, and the box and blocks test.
The purpose of Aim 2 is to develop a functional pattern recognition controller for a wearable hand device assisting
gross hand -opening and –closing. Control of the open-source Hand Extension Robot Orthoses (HERO) grip
glove, a powered orthosis to support hand function, will be advanced. Decoded movement intentions from a real-
time and online pattern recognition myoelectric controller will be incorporated into the control scheme. User
functionality will be assessed with and without the hand portion of SHAPE through measuring hand range of
motion, Fugl-Myer upper-extremity assessment, and the box and blocks test.
The same measures will then be assessed using both aspects of SHAPE simultaneously to detect possible
additional improvements. It is hoped SHAPE can improve function and quality of life for Veterans with stroke.

Public health relevance
Fifteen thousand Veterans are hospitalized with stroke related diagnoses each year. Approximately half are left with permanent and significant disability of their shoulder, arm, and hand, including extreme weakness and abnormal muscle activity. Thus far, rehabilitation therapy has resulted in limited gains. Efforts to use the shoulder often result in unintentional muscle contractions through the rest of the arm making functional use even more challenging, leading to a pattern of disuse. One solution is to support the shoulder and hand with a combination of two exoskeletons to compensate for the weakness and minimize these abnormal muscle contractions. Supporting the shoulder with a wearable device is novel and necessary to regain maximal range of motion and function after stroke. Once realized, it is hoped that the combination of these two wearable devices named, Shoulder-Hand Active-Passive Exoskeleton (SHAPE) can support the Veteran in his or her activities of daily living, encourage the use of their affected arm, and ultimately improve function and quality of life.